Genetic regulation of epithlial injury in ulcerative colitis

ABSTRACT
Ulcerative colitis (UC) affects nearly one million US adults. Refractory disease is still common, and the current
trial-and-error treatment approach causes delays in identifying optimal therapy for individual patients. Anti-TNF
remains a commonly prescribed biologic for UC, but approximately one-third of patients fail to respond and
about one-third lose response over time. Understanding the role of IBD-associated genes in intestinal epithelial
cell (IEC) injury, especially in determining therapy response or resistance, is a critical unmet need for aligning
patients with effective treatment options. Our long-term goal is to develop cytoprotective strategies and identify
formalin-fixed, paraffin embedded (FFPE) tissue signatures that correlate with therapy response. The objective
of this proposal is to elucidate IEC injury pathways that govern anti-TNF therapy effectiveness, and to discover
predictive biomarkers in FFPE biopsies indicative of anti-TNF treatment outcome. Our rationale is that TNF-
dependent and independent mechanisms of IEC injury dictate anti-TNF therapy response or resistance. Our
novel approach employs an innovative mouse model, A20/Abin-1T-ΔIEC, exhibiting severe colitis that mirrors
anti-TNF refractory UC. This model is instrumental in identifying TNF-independent pathways of intestinal injury.
Complementing this mouse model, we will apply pioneering spatial transcriptomics assays to analyze archived
FFPE patient biopsies, revealing treatment response signatures in routinely collected samples. Predictive
biomarkers in FFPE biopsies would integrate best with current clinical workflows, since nearly all IBD patients
have archived FFPE biopsies. Additionally, we leverage well-characterized colonic organoids derived from
healthy controls and UC patients for mechanistic in vitro assays to characterize primary IEC responses to
death stimuli.
The specific aims include:
1. Delineating TNF-independent (anti-TNF refractory) mechanisms of IEC death via the A20/Abin-1T-ΔIEC
mouse model, hypothesizing that IL-1B signaling is a crucial driver of mucosal injury.
2. Validating IEC injury pathways correlated with anti-TNF treatment response and non-response in FFPE
specimens, using a customized gene panel for detailed spatial transcriptomics.
3. Assessing differential sensitivities of UC-derived IEC organoids to death stimuli and cytoprotective
factors, hypothesizing a distinct response pattern in UC-derived organoids compared to controls.
This proposal integrates a novel mouse model, advanced spatial transcriptomics, and patient-derived organoid
cultures to pinpoint critical mechanisms of IEC injury and develop biomarkers indicative of anti-TNF treatment
response. By advancing this research, we aim to significantly impact precision medicine for UC, aligning
medications to individual patient epithelial biology, while identifying new therapeutic targets.

Public health relevance
PROJECT NARRATIVE Our research addresses the urgent need to understand and treat Ulcerative Colitis (UC), a debilitating condition affecting nearly a million patients in the United States. By integrating innovative mouse models of epithelial injury, advanced analysis of the genes expressed in tissue sections, and culturing the cells that line the intestine, we aim to uncover the fundamental mechanisms by which genetic factors contribute to refractory colitis. This work has the potential to develop precision medicine algorithms for choosing the best therapy for each patient up front, rather than a trial-and-error approach.